Neurodevelopment of Tourette syndrome

Like other complex neuropsychiatric disorders, Tourette syndrome (TS) is thought to be a result of primary
genetic/developmental abnormalities, long-term compensatory phenomena, and environmental factors. Despite
having one of the highest familial recurrence rates among complex neuropsychiatric disorders, few gene variants
achieving genome-wide statistical thresholds, and no definitive biomarker has emerged so far. Cortico-striatal-
thalamo-cortical (CSTC) circuits have long been implicated in TS by neuroimaging studies, and postmortem
analyses have suggested a decrease in number of striatal cholinergic and GABAergic interneurons in patients
with severe, long-term TS. In the past funding period, we confirmed the decrease in interneurons by single
nucleus RNA-seq (snRNA-seq) in the postmortem TS striatum. We also modeled human basal ganglia (BG)
development in organoids with patient-derived induced pluripotent stem cells (iPSC) to understand the time of
origin and potential developmental causes for the decrease in interneurons found in TS during adulthood. Basal
ganglia organoids from TS individuals fail to generate normal numbers of striatal cholinergic and
somatostatin/NPY GABAergic interneurons due to hypo-responsiveness to the sonic hedgehog (SHH) pathway,
suggesting an early developmental origin for the mature interneuron deficit in the TS brain. In the proposed
continuation of this research, in Aim 1 we will expand the postmortem snRNA-seq studies to additional regions
of the CSTC circuits in a much larger number of subjects (n=50 TS and 50 controls), to fully understand the
extent and the spread of the interneuron loss. In Aim 2, we will use BG organoids for parallel analyses of single
cell transcriptome, enhancer activity and 3D chromatin conformation to reconstruct the gene regulatory programs
that govern the development and maturation of BG cell types. We will then elucidate the alterations in
transcription factor (TF) activity and BG gene regulatory network downstream from SHH that are potentially
responsible for the deficiency in interneuron development in TS individuals. In Aim 3, we will use CRISPRa to
overexpress in TS organoids TFs that are upstream positive regulators of interneuron development to establish
whether this perturbation is sufficient to revert the loss of cholinergic and GABAergic interneurons back to control
levels. In a final set of experiments (Aim 4), we will perform lineage analyses to identify the precise cellular
mechanism of the interneuron loss in TS, i.e., whether there is a failure to allocate a sufficient number of
interneuron founder cells, a failed expansion of interneuron precursor lineages during development, or both.
These complementary experiments will define the time of origin, cellular and molecular pathophysiology of TS
and provide a disease model that can be used in future translational studies.

Public health relevance
In the proposed continuation of this research, we will expand the postmortem tissue studies to additional regions of the basal ganglia and cerebral cortex in a large collection of cases and controls. Using basal ganglia organoids, and single cell transcriptomic, epigenomic and cell lineage assays, we will map the differentiation and maturation of the various basal ganglia cell types, elucidate the alterations in organoids from TS individuals and perform reversal experiments to understand the sufficiency of key regulators in causing the TS phenotype. These complementary experiments will define the likely time of origin, cellular and molecular pathophysiology of TS and provide a disease model that can be used in future translational studies.